ANTIBIOTIC PEPTIDES AND PROTEINS OF ALVEOLAR MACROPHAGES

This proposal is designed to identify molecules, which may represent the macrophage's equivalent of the panoply of endogenous antibiotic polypeptides that exists in neutrophils. Primary reliance will be placed on a porcine AM model which affords large numbers of pure AM for classical biochemical characterization. In parallel with these studies, we will use micro-chemical techniques to identify the principal antimicrobial components of human and rat AMs.